Combinatorial pipeline for discovery of anti-GPCR Nanobodies

Antibody-based therapeutics are a $200 billion market, and is growing rapidly. Growth will be driven by the antibody
discovery sector fueling the demand and innovation. This underscores the need for advanced antibody discovery
platforms that efficiently can generate high-quality immune reagents. Existing pipelines encounter substantial screening
limitations: (1) Heavy dependence on purified proteins limits access to key antigens of great interest to the industry; (2)
The utilization of full antigens impedes targeted domain-specific strategies; (3) Single-antigen screening prevails,
hindering simultaneous assessment of multiple antigens in a combinatorial screening; (4) Current platforms lack precise
synthetic biology for comprehensive antibody and target antigen design, hindering advanced therapeutic
immunoreagent development by not integrating bioinformatics and AI effectively.
Biocognon's nanobody (NB) discovery pipeline leverages an advanced self-reporƟng yeast dual biosensor
technology, overcoming current field limitaƟons. This innovaƟon signifies a breakthrough in NB screening methodology
and in the future applicaƟons of these immunoreagents. Our system enables a 'many-on-many' combinatorial NB
screening mode, without the need for physically purifying target anƟgen or anƟbody and can uƟlize targeted domain-
specific strategies. As such, our pipeline possesses the precision to target the extracellular domains (loops and NH2-
termini) of G-protein coupled receptors (GPCRs).
G protein coupled receptors (GPCRs) are high-value therapeuƟc targets represenƟng around 30% of current
medicines. However, they are under-represented among biologic drugs, in part because current discovery methods are
poorly suited to address these small mulƟ-pass membrane proteins effecƟvely. We believe that Biocognon's innovaƟve
technology provides a superior means to discover bioacƟve nanobodies against human GPCRs. Discoveries are expected
to lead to development and commercializaƟon of new therapeuƟc treatments for mulƟple human diseases and
condiƟons.
In this project, we will demonstrate our innovaƟve combinatorial nanobody discovery platiorm for GPCRs
uƟlizing our yeast dual biosensor technology through three sequenƟal steps. (1) We will develop a robust 4-piece Golden
Gate assembly system, uƟlizing our validated yeast secrete and display vectors as a foundaƟon to facilitate efficient
assembly of GPCR/nanobody libraries with high complexity. (2) We will build a fully syntheƟc nanobody library system for
the human GPCRs ADRB1 and ADRB2 and conduct single screens to idenƟfy novel nanobodies to these GPCRs and
validate their therapeuƟc efficacy. (3) We will Implement a combinatorial screen against four GPCRs (ADRB1, ADRB2,
CXCR1, CXCR2) from two subfamilies to demonstrate a fully funcƟonal combinatorial nanobody discovery pipeline. If
successful, we will establish a robust foundaƟon to effecƟvely target the complete spectrum of the 400 druggable human
non-olfactory GPCRs. This innovaƟon in NB discovery is expected to lead to development and commercializaƟon of new
therapeuƟc treatments for mulƟple human diseases and condiƟons.

Public health relevance
We propose an innovative combinatorial nanobody discovery platform technology tailored to Human G- protein coupled receptors (GPCR) for the isolation of immune reagents using an advanced yeast secrete and display dual biosensor technology. Golden Gate genetic engineering will be used to generate complex combinatorial nanobody and target protein domain libraries that will be used in NB discovery utilizing fluorescence-based cell sorting methods. This platform will break through current limitations in screening technologies and will facilitate major developments and commercial release of new therapeutic treatments for various GPCR-based human diseases and conditions that benefit all.